Dopamine neurons in the zona incerta regulate feeding motivation

PROJECT SUMMARY
Zona incerta (ZI), a brain region located between the ventral thalamus and the hypothalamus, has been revealed
to regulate food intake by latest findings. We reported that g-aminobutyric acid (GABA) neurons in the ZI regulate
food intake through inhibitory projections to paraventricular thalamus (PVT). In addition to GABA neurons,
dopamine (DA) neurons have been found in the ZI for decades. However, little is known about their function in
the behavioral regulation. In our pilot studies, we used TH-Cre mice to target ZI DA neurons and found that
chemogenetic activation of ZI DA neurons potently increased motivation to obtain food reward. Based on our
pilot data, we hypothesize that: 1) ZI DA neurons regulate feeding motivation to control food consumption. 2)
ZI DA neurons encode feeding behaviors and respond to metabolic hunger signals. 3) the PVT serves as one of
the important postsynaptic areas for ZI DA neurons to exert the functional control on feeding. To test our
hypothesis, we will use adeno-associated viral vectors (AAVs) to induce Cre-dependent expression of excitatory
hM3Dq, inhibitory hM4Di, or ChR2 selectively in ZI DA neurons of TH-Cre mice. Chemogenetic activation and
silencing will be employed to selectively manipulate ZI DA neurons for testing their role in the control of food
motivation using progressive ratio (PR) schedule of reinforcement and real-time food consumption and meal
pattern using Feeding Experimental Devices (FED). We will also use optogenetics to selectively activate ZI DA
projections to determine the role of PVT neurons in feeding regulation induced by ZI DA neurons. In addition to
the behavioral studies, we will perform slice electrophysiology in combination with optogenetics to dissect
functional ZI DA pathways. In vivo fiber photometry will be applied to examine how ZI DA neurons encode feeding
behaviors including food seeking and consumption and slice electrophysiology will be used to study the activity
response of ZI DA neurons to metabolic hunger signals. Together, the proposed studies in this application will
reveal novel ZI DA pathways in feeding control. The expected outcome from the proposed studies will
significantly expand our view of how ZI and central DA signaling regulate feeding motivation and food
consumption.

Public health relevance
PROJECT NARRATIVE Obesity is primarily caused by an aberrant increase in feeding motivation that leads to the overeating of calorie- dense food. In this application, we propose to study zona incerta dopamine neurons for their role in the control of feeding motivation and food consumption. The expected outcome from this project will shed light on the mechanism by which central dopamine signaling regulate feeding and reveal a novel neural target for developing treatments in eating disorders and obesity.